Influence of Vitamin D Binding Protein on Clinical Measures of Vitamin D Status and Bone Health

PROJECT SUMMARY
This is an initial submission of a K23 application by Dr. Charles Ginsberg, under the mentorship of Dr. Joachim
Ix at the University of California San Diego (UCSD). Through this proposal Dr. Ginsberg intends to establish
himself as an independent investigator studying the chronic kidney disease-mineral bone disorder (CKD-MBD).
Candidate: Dr. Ginsberg's training objectives in this proposal include; 1)become proficient in the performance
of bone biopsies, 2)the interpretation of bone histomorphometry and 3)learn the necessary skills to develop a
research team and conduct clinical trials. Dr. Ginsberg will accomplish these objectives through mentorship,
coursework, and participation in workshops and steering committees. He has assembled a multidisciplinary
team of scientists including his primary mentor Dr. Joachim Ix, an expert in the CKD-MBD, Dr. Florin Vaida, an
expert biostatistician at UCSD, and Dr. Isidro Salusky a leader in bone biopsy performance and interpretation.
Research: Vitamin D deficiency is common among Americans and is known to lead to osteomalacia, rickets,
and fractures. Serum 25-hydroxyvitamin D [25(OH)D], the recommended clinical parameter to assess for
vitamin D deficiency, is flawed as there is conflicting evidence of association between 25(OH)D with bone
density and fracture risk. Dr. Ginsberg hypothesizes that the weakness of 25(OH)D as a marker for bone
health is, in part, due to variability in vitamin D binding protein (DBP). In Dr. Ginsberg's preliminary work he
demonstrated that the ratio of 24,25-dihydroxyvitamin D to 25(OH)D [the vitamin D metabolite ratio (VMR)] is a
superior marker of fracture risk in older adults, compared to 25(OH)D alone. The VMR is hypothesized to be a
marker of vitamin D status that is independent of DBP concentrations. In Aim 1, Dr. Ginsberg will evaluate the
relationship between 25(OH)D, other vitamin D metabolites, and the VMR with serum DBP concentrations
among 1,142 older adults in the Health, Aging and Body Composition (Health ABC) Study; an observational
cohort comprised of individuals with and without CKD. This will establish if the VMR is in fact independent of
differences in DBP concentrations. In Aim 2, Dr. Ginsberg will evaluate the associations between 25(OH)D,
other vitamin D metabolites, and the VMR with longitudinal change in bone density in the Health ABC Study
and will determine if accounting for differences in DBP influences these relationships. In Aim 3, Dr. Ginsberg
will evaluate the associations of 25(OH)D, other vitamin D metabolites, and the VMR with the degree of
unmineralized bone in patients with CKD undergoing bone biopsies. This will provide a direct pathological
correlate of bone disease and will determine the degree to which these relationships are influenced by DBP
concentrations. This will not only allow for a better understanding of the variability in bone pathology seen
across the spectrum of CKD but will also identify valuable biomarkers of the CKD-MBD and may ultimately
provide a more rational approach to measurement and treatment of vitamin D insufficiency.

Public health relevance
PROJECT NARRATIVE Vitamin D deficiency is common among Americans and can lead to decreased bone density and increased fractures. The current marker used to assess for vitamin D deficiency, 25‐hydroxyvitamin D may be flawed as it is not consistently associated with bone density and fracture risk. The objective of this proposal is to 1) evaluate the association between alternative markers of vitamin D status with change in bone density among 1,142 older adults in the Health, Aging and Body Composition (Health ABC) Study and 2) evaluate the association between alternative markers of vitamin D status with the degree of unmineralized bone in 50 patients with chronic kidney disease undergoing bone biopsy at the University of California, San Diego.